Aberrant chromatin regulatory mechanisms in Down syndrome brain

Project Summary: Maze I
!
Down syndrome (DS) is the most common genetic cause of intellectual disability worldwide resulting from
triplication of chromosome 21 (HSA21) in humans. Despite much progress in understanding the genetics of
DS, the genes encoded on HSA21–and beyond–that directly contribute to intellectual disability, as well as their
associated molecular mechanisms, remain incompletely understood. BRWD1 is an uncharacterized, brain
enriched chromatin `reader' protein encoded within the DS critical region 2 on HSA21. BRWD1 is believed to
act as a transcriptional activator via its proposed interactions with the SWI/SNF chromatin remodeling complex;
however, its roles in the contexts of neurodevelopment and in DS have yet to be studied. Consistent with
previous gene expression analyses in human DS brain, we observe that Brwd1 expression is significantly
elevated in trisomic mice, as well as in neurons derived from hiPSCs from DS subjects. Select histone
posttranslational modifications (PTMs), some of which we have already shown to directly interact with BRWD1,
are also altered in their expression. We have demonstrated that genetic re-normalization of Brwd1 expression
in Ts65Dn mice significantly rescues transcriptional dysplasticity associated with hippocampal LTP and
cognitive deficits in trisomic animals. Furthermore, exogenous Brwd1 overexpression–via viral-mediated
transduction of adult dorsal hippocampal neurons in wildtype animals–also leads to deficits in both contextual
and spatial memory. It is our hypothesis that BRWD1 trisomy in DS brain results in aberrant interactions
between BRWD1 and the epigenetic landscape, thereby contributing to global gene expression
abnormalities and cognitive deficits. We seek to test this hypothesis in the following independent, yet
synergistic Aims: 1) Examine the relationship between Brwd1 trisomy and chromatin dysfunction in DS-like
brain, with an overarching emphasis on a) unbiased assessments of histone PTM expression in DS-like
neurons and glia (+/– Brwd1 rescue) using cell sorting methodologies coupled to histone PTM mass
spectrometry, and b) delineation of direct interactions between BRWD1 and altered histone PTMs using highly
novel `designer' nucleosome-based assays and in vivo validations. 2) Investigate the impact of Brwd1
triplication on gene expression in DS-like brain. We aim to perform unbiased, epigenome-wide analyses of
Brwd1 enrichment–along with associated histone PTMs–in Ts65Dn brain, followed by extensive comparisons
with gene expression profiles obtained using cell-type specific RNA-seq. CRISPR-based manipulations will
subsequently be performed to directly assess Brwd1 target gene contributions to observed behavioral
abnormalities. 3) Explore the impact of Brwd1 triplication on recruitment/activity of specific SWI/SNF chromatin
remodeling complexes in Ts65Dn mouse brain using biochemical and genome-wide assessments. These
experiments will allow us to dissect the functional consequences of abnormal patterns of chromatin regulation
in DS brain and will aid in our understanding of the neuroepigenetic processes associated with brain plasticity.

Public health relevance
Project Narrative: Maze I Trisomy 21 (Down Syndrome – DS) is the most common genetic abnormality disorder in humans, with an estimated incidence of ~1 in 1,000 live births worldwide resulting from triplication of all or part of chromosome 21; however, genetic aneuploidy cannot fully account for many of the physiological and cognitive disabilities associated with this disorder. Here, we identify a novel, neuronally enriched epigenetic related protein, BRWD1, which is triplicated in DS and may, based upon strong preliminary data, play a significant and global role in the mediation of aberrant patterns of transcription, neurological plasticity and cognitive impairment associated with this disorder. Using a unique combination of biochemical, proteomic and genome-wide approaches, along with functional manipulations of downstream targets, we are investigating BRWD1's contribution–and more broadly, the contribution of aberrant epigenetic regulatory mechanisms–to DS associated neuronal impairments, with the hopes that such findings may aid in our basic understanding as to how epigenetic states shape fundamental neurodevelopmental processes that, when disrupted, lead to deficits in neurological plasticity and intellectual disability.